NIA AD/ADRD Health Care Systems Research Collaboratory

PROJECT SUMMARY
The NIA IMPACT Collaboratory COVID related supplement that funded the Long Term
Care Data Cooperative [U54AG063546-02S6] established a cooperative that is
compiling a centralized repository of nursing home electronic medical record (EMR)
data from three different EMR vendors. Numerous nursing home companies using one
of these three vendors have signed up as members, authorizing their EMR vendor to
transfer clinically relevant data, complete with identifiers, to a centralized repository
operating under the auspices of the American Health Care Association (AHCA) a
membership association of most US nursing homes [https://www.ahcancal.org/Data-
and-Research/Pages/LTC-Data-Cooperative.aspx]. In addition to the regulatory
required Minimum Data Set information, EMR data being consolidated include all
prevalent and incident diagnoses, orders, medication administration records, change of
condition records, daily vital signs, incident reports, vaccinations, behavior tracking,
daily changes in cognitive and physical functioning, and for some facilities, laboratory
and diagnostic test results.
To facilitate use of these data for the purpose of conducting public health surveillance,
in close collaboration with leadership and research analysts at the Centers for Disease
Control and Prevention, Brown University investigators propose to Investigate the
validity of infection data in the nursing home EMR by exploring the viability of using the
EMR data to identify two infectious conditions among nursing home residents. These
will be selected in consultation with CDC officials and could range from the occurrence
of SARS-CoV-2 and other pulmonary viruses to other common conditions like C-Difficile
with the goal of creating indicators of the incidence of each type of infection that
appears valid and reliably detected.

Public health relevance
Project Narrative Working closely with officials from the Centers for Disease Control and Prevention, Brown University investigators will use the data assembled in the Long Term Care Data Cooperative to investigate the viability and validity of these EMR data in identifying the incidence and prevalence of selected infectious conditions among nursing home residents.